Abnormal cytokine response and autoantigen production in IgA-producing subpopulations in IgA nephropathy

Abstract IgA nephropathy (IgAN) is the most common primary glomerulonephritis. It leads to end-stage kidney disease (ESKD) in 40-50% of patients. IgAN patients often exhibit macroscopic hematuria, commonly associated with upper-respiratory tract infections. This exacerbation of kidney injury seen during episodes of mucosal infection and inflammation suggests a connection between the two. In biopsies of IgAN patients, the defining characteristic of this disease is the deposits of polymeric IgA1, typically with IgG and complement C3 co- deposits. Analysis of the deposited IgA1 revealed enrichment for galactose-deficient IgA1 (Gd-IgA1) compared to circulatory IgA1. In addition, the co-deposited IgG is specific for Gd-IgA1. This appears to be immune complex deposition, which is also found in circulation of patients. Serum levels of Gd-IgA1 and anti-Gd-IgA1- IgG autoantibodies are elevated in IgAN patients, associate with disease progression, and can be found complexed in circulation. This circulatory autoantigen (Gd-IgA1) is typically found in the polymeric form, which is unique to the mucosal region. This suggests that a subset of IgA1-producing cells could be migrating from mucosal regions, or there is abnormal IgA1-producing cells formed elsewhere. Initial observations that mucosal infections associated with transient hematuria in IgAN patients led to the thesis that pro-inflammatory stimulation could increase circulatory Gd-IgA1-containing immune complexes, causing renal injury. We recently published that IL-6 stimulation in EBV-immortalized IgA1-producing cells from IgAN patients, but not controls, preferentially increased Gd-IgA1 production due to an enhanced and prolonged STAT3 activation. In addition, preliminary data in our lab from single-cell transcriptome profiling using immortalized IgA-producing cells from IgAN patients and healthy controls revealed multiple populations of IgA1-producing cells that have differential responses to cytokine stimulation. These observations led to our hypothesis that enhanced Gd- IgA1 production is a result of abnormal cytokine response in a subset of IgA1-producing cells. In Aim 1, we will test the hypothesis that cytokine exposure has differential effects on subsets of IgA1-producing cells in EBV- immortalized IgA1-producing cells from IgAN patients vs. healthy and disease controls. In Aim 2, we will test the hypothesis that subsets of IgA1-producing cells that have differential responses to cytokine stimulation are preferentially producing Gd-IgA1. The combination of these two aims will help identify the specific IgA1- producing cell subsets that contribute to autoantigen production. These studies will enable testing of novel research hypotheses and yield new preliminary data towards a competitive R01 proposal.

Public health relevance
Project Narrative/Relevance: The goals of this proposal is to identify subpopulations of IgA1 producing cells from IgA nephropathy patients and their abnormal responses to cytokine exposure that are responsible for autoantigen production. Success of this endeavor will provide insight into mechanisms that give rise to enhanced autoantigen production from B cells in IgA nephropathy patients which will aid in the development of novel therapeutics.